Core 1: Biostatistics Core

PROJECT SUMMARY
The goal of the GastroIntestinal Biostatistics and Bioinformatics Core (GI-BBC) is to
provide wide-ranging, high-quality statistical and bioinformatics support to the GI
SPORE. The primary aim of the GI-BBC is to assist GI SPORE investigators in the
design, conduct and analysis of laboratory and clinical studies proposed in this SPORE
application. The GI-BBC will focus its efforts on assisting both the clinical and laboratory
investigators in translating their pre-clinic studies into clinical studies by providing state-
of-the-art experimental designs and analyses through statistical consultation and in
collaboration with respect to methodology, feasibility, analysis, and reporting of clinical
and laboratory studies. In addition, the GI-BBC will serve as an ongoing resource for all
GI-SPORE investigators. The Core will be led by Dr. Sugar and Dr. Scharpf and Dr.
Rachel Karchin will act as a co-investigator. These GI-BBC faculty members have
complementary areas of expertise: Dr. Sugar in biostatistics specializing in translation
and clinical study design and analysis, Dr. Scharpf in the analysis of high-throughput
genomic assays, Dr. Karchin in computational genetics. Ms. Amanda Blackford, a
biostatistician in the Cancer Center, will assist Drs. Sugar and Scharpf in statistical
analyses. David McKean, a Master's level bioinformatics specialist will assist Dr.
Scharpf. Centralization of statistical needs within the GI-BBC core will provide SPORE
investigators with open access to a team of statisticians with the skill set necessary to
meet the current and future goals of the SPORE in a cost-effective manner. In addition,
it will facilitate communication across SPORE projects, aiding the translation of research
findings into the clinical setting.

Public health relevance
Narrative The goal of the GastroIntestinal Cancer Biostatistics and Bioinfromatics Core is to provide comprehensive statistical and informatics support to GI-SPORE investigators. This includes assisting GI-SPORE investigators in the design, conduct, and analysis of the laboratory and clinical investigations that will be conducted as part of this overall application.